The roles of intestinal epithelial AhR in alcohol-induced barrier dysfunction and liver injury

PROJECT SUMMARY
Throughout the COVID-19 pandemic, alcohol sales, use and related hospitalizations have dramatically
increased, disproportionately affecting minority communities. Alcohol impairs intestinal barrier function through
changes in tight junction protein expression. Alcohol-induced intestinal permeability leads to endotoxin from gut
microbes leaking out and traveling through portal circulation to prime the liver for injury. The aryl hydrocarbon
receptor (AhR), a ubiquitously expressed transcription factor involved in the clearance of xenobiotics and
maintenance of immune cell function, has been implicated in the maintenance of intestinal barrier function. AhR
activation with dietary ligands has been shown to improve intestinal barrier function in models of inflammation.
Furthermore, alcohol-induced gut permeability and liver injury have been shown to be partially attenuated with
AhR ligands. However, these limited studies have not examined the role of cell specific AhR signaling in the
maintenance of intestinal barrier function in response to alcohol. Our preliminary data demonstrate that the
combination of intestinal epithelial specific (IEC) AhR knockout and treatment with the AhR ligand β-
naphthoflavone (BNF) provides protection against alcohol induced gut permeability and liver injury. We
observed i) decrease in ethanol-induced endotoxemia (intestinal permeability marker), ii) decrease in the
induction of serum alanine aminotransferase (ALT; hepatic injury marker), and iii) induction of AhR target genes
in ileal mucosa. Previous studies have shown that intestinal epithelial AhR regulates availability of dietary AhR
ligands to immune cells. Therefore, we hypothesize that the absence of intestinal epithelial AhR increases
the availability of AhR ligands to intestinal immune cells, leading to an increase in immune AhR
signaling, and IL-10 and IL-22 mediated improvement in ethanol induced intestinal barrier permeability
and subsequent protection to liver injury. The studies proposed in Specific Aim 1 will elucidate the
mechanisms of intestinal epithelial and immune cell specific AhR on alcohol mediated gut permeability—with
focus on differences between the small and large intestines—and liver injury using intestinal epithelial and
immune cell specific AhR knockout mice. These studies will also delineate the ethanol induced changes in
microbial metabolites and their role in AhR activation by reporter assays. Specific Aim 2 will utilize state-of-the-
art intestinal epithelial enteroid-immune cell co-cultures to study the crosstalk between IECs and immune cells
in mediating alcohol induced gut permeability. Overall, the successful completion of the proposed work could
have profound implications for the treatment of intestinal barrier contributing liver injury such as in alcoholic liver
disease. All experiments will consider variations that may arise from sex differences, with attention to statistics
and reproducibility. The proposed studies will provide comprehensive training for the applicant and identify novel
therapeutic targets to aid intestinal barrier function and allow for intervention in alcohol use disorder.

Public health relevance
PROJECT NARRATIVE Alcohol related hospitalizations have been on the rise throughout the COVID-19 pandemic and intestinal barrier function has been shown to play a key role in the development of alcohol induced liver injury. Our proposed studies will reveal a very new cell-type specific mechanism by which intestinal epithelial and immune cells cross-talk in terms of signaling of a very important protein called Aryl Hydrocarbon Receptor (AhR) to restore the damage caused by alcohol on the gut and the liver.